Prosthetic Joint Infection After Primary Total Knee Arthroplasty: Incidence, Microbiology and Risk Factors

PROPOSAL SUMMARY
Total knee arthroplasty (TKA) is one of the most common surgeries performed in the United States (US).
Prosthetic joint infections (PJI) are the most serious complication of this procedure, with high morbidity to patients
and a large economic burden to the healthcare system. Despite the frequency of TKAs being performed in the
US and the adverse impact of PJIs, the incidence, organisms implicated in these infections, and the risk factors
for development of PJI after TKA remain unknown in the US.
To begin to address these knowledge gaps, we will assemble a national cohort of patients who underwent TKA
within the Veterans Health Administration (VA), the largest integrated health system in the US. In our first aim,
we will determine the incidence and microbiology of PJI within the first year after TKA and compare results to
those who develop PJI more than a year after TKA. We will compare results across these two time periods
because infections developing <12 months after joint replacement typically arise from the introduction of skin
and commensal bacteria into the surgical incision during or shortly after the surgery, whereas infections occurring
12 months after joint replacement typically arise from hematogenous seeding or local trauma. This aim will
identify the time period of highest PJI incidence, furthering our understanding of the pathophysiology of these
infections, and will inform the choice of empiric antibiotic therapy for PJI that develop during these two periods.
In our second aim, we will evaluate host and surgical factors associated with PJI, regardless of the time that PJI
developed; in a secondary analysis, we will explore if there are differences in risk factors between early and late
PJI. This aim will assess the relative strength of association of risk factors, which will guide future interventions
to reduce PJI rates.
These results will help determine the timing of highest risk of PJI after TKA, identify the subgroups of TKA
patients at highest risk for PJI for closer monitoring, and inform clinicians’ empiric antibiotic treatment decisions
during suspected PJI. In addition, the training provided by this award will afford the applicant with skills important
for her development into an infectious diseases epidemiologist, with the goal of becoming an independent
investigator. The proposed training plan includes advanced epidemiologic and biostatistical coursework in the
Center for Clinical Epidemiology and Biostatistics at the University of Pennsylvania, as well as mentorship from
researchers in epidemiology, biostatistics, infectious diseases, and orthopedic surgery.

Public health relevance
PROJECT NARRATIVE Prosthetic joint infection is a serious complication of total knee arthroplasty, which is one of the most common surgical procedures in the United States. The objective of this study is to compare the incidence and microbiology of these infections in the early and late post-operative periods and identify patient and surgical risk factors for their development. The results of this study will be useful in identifying patients at high risk for a prosthetic joint infection and inform clinicians on the appropriate empiric antimicrobial therapy that should be initiated when this infection is suspected, with the purpose of decreasing patient morbidity and the economic burden of these infections.